Non-Coding RNAs: Biology and Applications

ABSTRACT Support is requested for a Keystone Symposia conference entitled Non-Coding RNAs: Biology and Applications, organized by Drs. David L. Spector, Ling-Ling Chen and Anna Marie Pyle. The conference will be held in Palm Springs, California from May 10-14, 2021. A large number of long non-coding RNAs (lncRNAs) with a surprisingly wide-range of cell-type specific expression profiles are present in human transcriptomes. Emerging evidence points to their critical roles in human physiology and pathology and some are recognized as potential therapeutic targets. However, many seminal questions regarding their mechanism of action remain largely unexplored. There is a need to understand how different regulatory RNAs are processed and regulated, how they act in different physiological and disease contexts, how their essential structural modules are built, organized, and interact with proteins and other RNAs in the cell to carry out their functions. Additionally, there is a need to elucidate how the fundamental biology of regulatory RNA can be translated to therapeutic approaches. Therefore, this conference will bring together scientists who study the basic biology of diverse types of ncRNA molecules from generation and processing, structure, mechanisms of action to functional significance in different model organisms, as well as those who develop cutting-edge RNA technologies, biomarkers and medicines for translational purposes. It is anticipated that this conference will provide an integrated platform for scientists to communicate the latest innovative technologies and methodologies that will speed up the exploration of both fundamental regulatory RNA biology and translational applications.

Public health relevance
PROJECT NARRATIVE Emerging evidence of long non-coding RNAs (lncRNAs) points to their critical roles in human physiology and pathology, as well as recognition for their use as potential therapeutic targets. However, most aspects of our knowledge of lncRNAs remains largely incomplete but is crucial to help define the contribution of lncRNAs to cellular function in physiological and pathological states. Therefore, this conference will highlight both the progress and roadblocks in the field, as well as provide an integrated platform for scientists to communicate the latest available innovative technologies and methodologies that will speed up the exploration of both fundamental RNA biology and medical applications.